VALIDATION OF SMART PHONE APPLICATION FOR NATURALISTIC DRIVING RESEARCH

The NICHD Division of Intramural Population Health Research (DIPHR), is collecting data on novice teenage driving risk. smartphones can be leveraged for driving research. G-force events and mileage driven can be captured using accelerometers and global positioning (GPS) technology. Theses measures form basis of calculating g-force events and rates.